Unraveling the mechanisms of cell-mediated Chlamydia systemic dissemination.

PROJECT SUMMARY/ABSTRACT
Recently WHO estimated that more than 1 million new STIs are acquired daily. In 2016 of about 376 million
new STIs, 127 million were caused by Chlamydia. In the US, Chlamydia continues to be a leading cause of
STIs, with 1.7 million cases of approximately 2.3 million STIs reported in 2017. Chlamydial infections in women
may result in cervicitis, salpingitis, pelvic inflammatory disease, causing infertility or life-threatening ectopic
pregnancy. Moreover, chlamydial STIs in women are associated with increased transmission of HIV and an
increased risk of cervical cancer when co-infected with HPV. In spite of great efforts, the development of
mucosal vaccines that target Chlamydia has been unsuccessful. In the mouse model of infection, Chlamydia
spreads from the female reproductive tract (FRT) to infect and persist in the gastro-intestinal tract (GIT). GIT
infections with Chlamydia also occur in humans. In mice, following FRT infection Chlamydia muridarum (Cm)
disseminates systemically in stages, by first infecting the FRT-draining iliac lymph nodes (ILNs), then the
spleen, and the GIT. Cm dissemination relies on carriage by migrating host cells. Inhibition of cell migration in
CCR7-/- mice or in mice treated with FTY720 diminishes or abrogates Cm spread to the spleen and the GIT.
Moreover, removal of the spleen drastically reduces Cm infection of the GIT. Most importantly, removal of the
spleen hinders Cm ascension in the upper FRT and abrogates the FRT pathology. We hypothesize that the
spleen is a permissive site for Cm proliferation and that circulating infected cells contribute to Cm spread to the
upper FRT. Therefore, the knowledge gained from the proposed work will improve our understanding of FRT
immunobiology, cell migration, Chlamydia pathogenesis, and will be important for the development of vaccines
and therapies to target this pathogen.

Public health relevance
PROJECT NARRATIVE In animals and humans, Chlamydia infects the female reproductive tract (FRT) and the gastro-intestinal tract (GIT). In the mouse model of infection we showed that during the FRT to GIT Chlamydia spread by infected migrating cells, infection of the spleen represents a critically important event, as splenectomized mice do not develop upper FRT pathology. In this application, we aim to test our hypothesis that following FRT infection Chlamydia infects and survives within host cells, which in turn carry it to other sites in the body thus enabling its systemic spread, including to the upper FRT, which is critical for the development of long-term FRT pathology.